Elucidating the Mechanisms of Lymphatic Muscle Cell Dysfunction in Aging and Inflammation

Project Summary/Abstract.
Lymphatic dysfunction is known to be associated with various disorders involved in both aging and
inflammation, such as Alzheimer’s disease, cardiovascular decline, and arthritic progression. Throughout
aging, lymphatic contractility has been shown to deteriorate related to reduced gene expression of essential
pathways that mediate homeostatic contractions and cytoskeletal integrity in lymphatic muscle cells (LMCs).
Similarly, we previously discovered that age-dependent cellular mechanisms of lymphatic dysfunction in the
tumor necrosis factor transgenic (TNF-Tg) mouse model of chronic inflammatory arthritis are associated with
progression of joint disease and the loss of joint-draining popliteal lymphatic vessel (PLV) contractions in aged
mice. In these aged mice, the PLV demonstrates significant LMC atrophy at an ultrastructural level, which is
proposed to drive the elimination of lymphatic function and exacerbate disease progression. As a clinical
correlate, we have found that patients with active rheumatoid arthritis have fewer functional LVs and
diminished lymphatic clearance on the surface of the hands. Thus, we hypothesize that inflammation mediates
accelerated age-related damage to LMCs where inflamed LMCs will exhibit a comparable dysfunction in the
gene pathways necessary for LMC contractility and cytoskeletal integrity. To test this hypothesis, we propose
to assess alpha smooth muscle actin (αSMA)+ PLV-LMC coverage and investigate transcriptional changes by
single cell RNA sequencing (scRNAseq) in young (2-month-old), aged (8-month-old), and elderly (24-month-
old) WT and TNF-Tg mice. Towards this goal, we have demonstrated that αSMA+ PLV-LMC coverage is
reduced in aged (8-month-old) TNF-Tg mice relative to WT littermates. Additionally, we achieved preliminary
success in scRNAseq of aged LMCs to indicate the feasibility of this approach. Given the inadequate
characterization of LMCs necessary for targeted research into their role in health and disease, our scRNAseq
data also provides evidence that LMCs are transcriptionally distinct vascular muscle cells. Through the
completion of the research aims embodied in this grant proposal, we have the opportunity to provide
considerable innovation for future pre-clinical research and targeted therapeutic interventions of LMCs. In line
with the applicant’s Research Training Plan, the PI will gain valuable experience primarily in bench research
with additional opportunities to foster abilities in clinical trial design, medical care, academic leadership, and
community outreach at the University of Rochester with a cherished history of producing successful physician-
scientists. For the following PA-21-049 F30 grant submission, we propose to elucidate the mechanisms of LMC
dysfunction during both aging and inflammation for the benefit of lymphatic cellular biology and our
understanding of the enigmatic age-related progression of arthritis.

Public health relevance
Project Narrative. Lymphatic dysfunction is a novel frontier in the understanding of various age-associated pathologies, such as Alzheimer’s disease, cardiovascular failure, and arthritic progression. While innovative research has recently implicated a role for lymphatic contractility as a potential therapeutic target in disorders with lymphatic deficiencies, the field of lymphatic biology is limited in the actualization of focused research in this area of immense opportunity due to an inadequate understanding of lymphatic muscle cells in health and disease. Through this grant proposal emphasizing the foundational characterization of lymphatic muscle cells across aging and in the age-related progression of inflammatory arthritis, we are venturing into an incredibly understudied niche of scientific inquiry providing promise for discoveries that will alter the landscape for our ability to understand the pathogenesis of age-dependent diseases and beyond.